Strategic Conference of Zebrafish Investigators

PROJECT SUMMARY
We propose a continuation of the annual Strategic Conference of Zebrafish Investigators (SCZI), the main
meeting of principal investigators using the zebrafish model. Previously, this was a biannual conference
held in Asilomar, USA. In 2019, the International Zebrafish Society collaborated with the European Zebrafish
Society to adopt a 3-year rotation schedule for both their larger International Zebrafish Conference (IZFC)
gathering zebrafish researchers at all career stages and the SCZI so that the locations will rotate between
US/Canada, Europe, and Asia-Pacific. This new, focused meeting structure aims to promote greater international
collaboration by reducing the total number of international conferences, supporting the goals of both societies to
increase inclusivity and to reduce the travel-associated carbon footprint. The SCZI is a prime venue for zebrafish
principal investigators to discuss current research and promote coordinated advancement of research using
zebrafish as a model system (as well as connections to related, emerging aquatic models). The meeting will
accommodate up to 200 principal investigators. The proposed 10th SCZI meeting will take place in 2024 in
Asilomar, CA; continuation of the series will follow in Europe 2025, Asia-Pacific in 2026, and so on.
The zebrafish has become a powerful model organism for the genetic analysis of vertebrate
development. Moreover, the zebrafish has emerged as a versatile vertebrate system to model human diseases
and discover underlying mechanisms, especially when used in conjunction with other vertebrate models, and to
screen for therapeutics and toxins. Advances in forward and in particular, reverse genetics, imaging techniques,
transgenesis, and chemical screening are rapidly and widely disseminated throughout an active, collaborative
community that has grown in coherence and connectivity through international meetings. The proposed SCZI
meeting will continue to foster the critical development of resources, establishment of collaborations,
and expansion of interdisciplinary interactions. Importantly, one third of past participants have been new
investigators: in addition to the open access to new findings in the field and to establish collaborations, new
investigators will have the opportunity to attend discussion sessions on topics such as grant writing and balancing
professional development and personal growth chaired by senior investigators. Past meetings have had a solid
record of inclusion of women and minority participants, and we will continue to provide inclusive
meeting environment.
This grant will provide financial assistance for up to 30 US-based junior laboratory heads to attend the
conference. Recipients of financial support will be chosen based on the impact and originality of their abstracts
as well as considering gender, race, career stage, and need.

Public health relevance
PROJECT NARRATIVE The zebrafish is well established and accepted as a scientific model system for studying vertebrate development and as a model to study human disease and disorders, including alcohol and drug abuse, cancer, infectious disease, and neurodegeneration. The long-standing Strategic Conference of Zebrafish Investigators (SCZI) brings principal investigators from all scientific disciplines together to exchange ideas, share new methodologies, form collaborations, foster resource development, and draw strategic plans for the optimal use of the zebrafish model in basic and biomedical research. This proposal seeks support for five future SCZI conferences as a successful annual series to allow principal investigators to strategically discuss current research, approaches, and challenges, to integrate new members of the zebrafish community, and to promote coordinated advancement of research using the zebrafish model system.